Cerebrospinal fluid dynamics in Huntington's disease

PROJECT SUMMARY
The overall objective of this work is to apply innovative neuroimaging methods of cerebrospinal fluid (CSF)
production, transport, and resorption in patients with Huntington’s disease (HD) to test fundamental hypotheses
regarding the sequelae of aberrant neurofluid circulation in HD participants. New intrathecally administered
ASOs have gained great interest as a disease-modifying treatment in HD, and yet in HD, these interventions
have resulted in increases in neurofilament light protein (NfL) levels, and greater ventricular volumes.
Importantly, post-hoc data indicates some may benefit from these interventions, and new trials are being
developed. Heterogeneity in treatment response may be explained by CSF flow dysfunction. The recent proposal
of the glial-lymphatic system has highlighted the importance of neurofluid circulations. For instance, the current
paradigm describes CSF circulation as a combination of perivascular, interstitial, and bulk flow pathways. The
CSF is produced by the choroid plexus (ChP) complexes, traverses the brain parenchyma along peri-arterial and
peri-venous pathways, and exits the brain along parasagittal dural (PSD) space, cranial nerves and through
dural venous sinuses. We have established a collaborative effort between neurologists, imaging
scientists, and neuroradiologists to investigate quantitative changes in neurofluid circulation in the setting of
neurodegeneration. These investigations provide a more comprehensive perspective on neurofluid production
and flow and allow for sequential assessments of choroid plexus (ChP) perfusion, CSF flow and velocity, and
volumetric assessments of the parasagittal dural space (PSD), with established relevance in neurofluid egress.
Using these approaches, we have characterized age-related declines in ChP perfusion and net CSF flow, and
increases in ChP and PSD volume, across the healthy lifespan in 80 healthy adults, demonstrated that a subset
of these markers including PSD hypertrophy directly correlate with proteinopathy extent in 24 older adults with
neurodegenerative proteinopathies, and, in preliminary data motivating this project, that these same trends
persist in 29 patients progressing from pre-manifest to manifest stages of HD on a more accelerated
timescale. We propose to apply these methods for the first time to characterize the range of neurofluid
aberrations more fully across HD stages; to differentiate choroid plexus pathology, characterize CSF
movement through the cerebral aqueduct and brain cisterns, and peri-sinus space anatomy with the
quantification of PSD across HD stages. Data collected during this project are intended to further inform our
understanding of HD pathophysiology and provide biomarker ranges that will be required to rigorously
inform a future trial based on personalized signatures of hypothesized responsiveness.

Public health relevance
NARRATIVE Promising disease-modifying therapies using intrathecally administered antisense oligonucleotide seek to reduce mutant huntingtin protein expression and offer disease modifying potential in Huntington’s disease. Previous iterations of these interventions have resulted in an increase of neurofilament light protein levels and greater ventricular volumes, but post-hoc data indicates that some patients (younger and earlier in disease stage) may benefit from these interventions. This project aims to improve our understanding of the CSF flow circuit in HD, assess heterogeneity in treatment response, and discover new mechanisms of pathophysiology by assessing production, flow, and absorption of CSF across the stages of HD.